Impact of Medicaid Postpartum Coverage Extension and Mandated Postpartum Depression Screening on Care for Gestational Diabetes and Pregnancy-Induced Hypertension

Abstract
Both gestational diabetes mellitus (GDM) and pregnancy-induced hypertension (PIH) affect pregnancy, birth
outcomes, and postpartum care. They are independent risk factors for diabetes mellitus (T2DM), hypertension
(HTN), and mental health conditions such as postpartum depression (PPD). Despite recommendations that
postpartum care should include blood pressure (BP), blood glucose (BG) monitoring, and PPD screening,
current postpartum care practices have low screening rates, especially among Medicaid beneficiaries. While
Medicaid covers nearly half of deliveries in the United States, many birthing people lose coverage 60 days
after birth. The American Rescue Plan Act of 2021 provided states with federal funding to extend postpartum
coverage up to 12 months – Louisiana has done so while Mississippi has not. Additionally, on August 1, 2022,
Louisiana enacted a statewide mandate requiring providers of postnatal care to screen for PPD and related
mental health disorders. Using our collaboration with the National Birth Equity Collaborative and combined
expertise, we propose to evaluate the effects of the Medicaid postpartum extension (MPE) and PPD screening
mandate on screening behaviors, health outcomes, and patient experiences in Louisiana (LA) compared to
Mississippi (MS) over three periods (early 2022-2023, middle 2024-2025, and late 2026-2027). We will link
electronic health records and Medicaid claims data in Louisiana and Mississippi, allowing us to track screening
and follow-up care even after birthing people lose Medicaid coverage. The primary effectiveness measure will
be a 3-month composite screening rate for BP, BG, and PPD. Secondary measures include individual
screening rates, diagnoses, and management of T2DM, HTN, and PPD. It is also critical to understand
contextual factors and health inequities that contribute to disparities in postpartum care and to estimate the
cost-effectiveness of these policies. The overall goal is to evaluate effective implementation strategies that aim
to improve maternal postpartum health in Medicaid beneficiaries with GDM or PIH. To achieve this goal, the
study will have three specific aims. First, we will examine the effectiveness of Louisiana’s MPE and PPD
screening mandate on the rates of BG and BP monitoring, PPD screening, rates of T2DM, HTN, and PPD
diagnoses, T2DM, HTN and PPD management, health disparities, and health care utilization, as compared to
counterparts in Mississippi. The second aim will be to examine the cost-effectiveness and distributional cost-
effectiveness of Louisiana’s MPE and PPD screening mandate from the patient, provider, payer, and social
perspectives. The third aim will be to examine the complex contextual factors that influence adopting and
implementing MPE and PPD screening mandates, and subsequent impacts on healthcare delivery, healthcare
utilization, and maternal health equity within and between Louisiana and Mississippi. Findings will inform
concurrent and future health policy strategies for informing, engaging, and empowering birthing people to
improve maternal health outcomes and eliminate maternal health disparities in the United States.

Public health relevance
Narrative We propose three waves of health policy evaluations (early 2022-2023, middle 2024-2025, and late 2026- 2027) of the Medicaid postpartum extension (MPE) and postpartum depression screening mandate in Louisiana, compared to Mississippi. The intended outcome will be to evaluate the effectiveness and contextual factors of implementation strategies that aim to improve maternal postpartum health and health equity. This study will generate urgently needed data on practical, robust, and sustainable population-targeted strategies to improve maternal health outcomes, reduce maternal health risks, and eliminate maternal health disparities in the United States.